Data Analysis Core

The Data Analysis Core (DAC) will centralize computational analysis for the JHU-Mayo-NIA Murine
Senescence Mapping Program (JMN-MSMP) to generate integrated molecular and spatial maps of cellular
senescence in aging murine tissues. The JMN-MSMP will generate data from bulk RNA sequencing, single cell
RNA sequencing (scRNA-seq), chromatin accessibility sequencing (scATAC-seq), spatial transcriptomics, and
multi-spectral imaging, among others. The DAC will provide essential expertise and services to translate this
raw data into knowledge. More specifically the DAC will be responsible for the following tasks.The DAC will: 1)
provide essential analysis pipelines, computational expertise, and data management services in support of the
Biological Analysis Core (BAC); 2) incorporate state-of-the-art methods for analysis of data from cutting-edge
technologies, as well as integration and visualization of unique data resources generated within the JMN-
MSMP as these methods reach maturation; 3) lead the construction of the Atlas itself; and 4) coordinate
analysis activities with the other SenNet Centers and the CODCC to standardize pipelines and contribute
unique multi-omics and transfer learning expertise. The DAC will provide standardized and rigorous analysis
pipelines optimized for the goals of SenNet, and use the pipelines to generate findable, accessible,
interoperable, and reusable (FAIR) data.